Maintenance of Animal Feed Regulatory Program Standards and Implementation of Preventive Controls Regulatory Activities and Capacity

PAR-20-132: Washington State Department of Agriculture (WSDA) - Animal Feed Program
Maintenance of Animal Feed Regulatory Program Standards and Implementation of Preventive
Controls Regulatory Activities and Capacity
PROJECT SUMMARY/ABSTRACT
WSDA seeks funding from the U.S. Food and Drug Administration under PAR-20-132 for
Animal Feed Regulatory Program Standards (AFRPS) Maintenance Phase Track Tier Level 2
and Preventive Controls for Animal Food (PCAF) Funding Option. The project intention is to
maintain and improve our program with AFRPS and to expand our ability to implement the
Preventive Controls for Animal Food (PCAF) Rule which advances efforts for a nationally
integrated food safety system by encouraging the safe manufacturing and processing of animal
food and promoting understanding and compliance with PCAF requirements. This proposal
explains how we will ensure AFRPS is sustained and increase the number of staff to meet the
needs for project deliverables; such as training and auditing. We also will assist industry through
outreach to aid their understanding of PCAF and support them to successfully develop
compliant animal food safety manufacturing and monitoring systems.
We also recognize the importance of mutual reliance and program efficiency. We are currently
in the process of incorporating into our Division’s database project. Our collaboration will help
expand our new database to allow it to communicate with FDA. The enhanced electronic
communication and cooperative enforcement will support Food Safety Modernization Act
(FSMA) overall goals of food safety, mutual reliance and efficient work planning while
supporting the Division’s mission to promote food integrity, safety and availability. Additionally,
the goals of this project will support the Animal Feed Program’s mission to regulate the safety
and integrity of animal food, to protect animal and public health and ensure market fairness.
WSDA meets all eligibility requirements for this funding opportunity:
• WSDA is a State Government agency
• WSDA has received 5 years of funding under a past AFRPS Cooperative Agreement (exp.
8/31/2020). Verification audit scheduled for August 2020. Any items deemed partially
implemented are/will be addressed in our strategic improvement plan and corrected.
• WSDA has a current FDA animal food safety inspection contract

Public health relevance
PAR-20-132: Washington State Department of Agriculture (WSDA) - Animal Feed Program Maintenance of Animal Feed Regulatory Program Standards and Implementation of Preventive Controls Regulatory Activities and Capacity PROJECT NARRATIVE The Washington Department of Agriculture PAR-20-132 project intention is to maintain and improve our program with the Animal Feed Regulatory Program Standards (AFRPS) and to expand our ability to implement the Preventive Controls for Animal Food (PCAF) Rule. Overall, our goal aligns with PCAF Rule to advance efforts for a nationally integrated food safety system by encouraging the safe manufacturing and processing of animal food and promoting understanding and compliance with the requirements of the PCAF Rule. This proposal explains how we will ensure AFRPS is sustained and increase the number of staff to meet the needs for all project deliverables, including for training and auditing. We also included in our proposal to assist the feed industry, particularly small and very small feed businesses through outreach to enhance and improve their understanding of the PCAF requirements and support them to successfully develop PCAF compliant animal food safety during manufacturing, packing, handling and holding of their animal food products as well as their monitoring systems.